Behavioral Measurement and Population Science

Behavioral Measurement and Population Science Shared Resource
Project Summary/Abstract
The University of New Mexico Comprehensive Cancer Center (UNMCCC) Behavioral Measurement and
Population Science Shared Resource (BMPS) supports basic and translational cancer research by providing a
continuum of services including research design and development, data collection and data management,
qualitative data analysis, accrual reporting facilitation, and training to UNMCCC members and non-member
users. Resource Director Andrew Sussman, Ph.D., MCRP (CCPS) and Associate Director Dolores Guest,
Ph.D., RD (CCPS) supervise BMPS, which is operated by a full-time staff including experienced Cancer Control
& Population Science (CCPS) researchers. The Cancer Center Research Administration (CCRA) supports the
administrative needs of the Resource, which includes fiscal management, hiring, purchasing requests related to
supplies and equipment, and travel reimbursements. BMPS leadership oversee billing and usage and manage
all project tracking. The Resource Director and staff work closely with UNMCCC research programs to develop
new methodologies that promote innovative basic and translational research goals. BMPS actively facilitates and
disseminates information about new population science technologies by maintaining an up-to-date web page
and library and by giving presentations at UNMCCC meetings and retreats. During the previous 5-year project
period, 22 Principal Investigators, 21 of which are UNMCCC members from two of UNMCCC’s three Research
Programs, used BMPS to support 16 peer-reviewed grant funded projects, 20 peer-reviewed Cancer Center pilot
projects and an additional 7 CCSG Supplement and 1 P20 Supplement studies for a total of 44 projects.